The Role of Endocannabinoids in Adulthood Alcohol Drinking After Adolescent Social Isolation

PROJECT SUMMARY
Chronic stress during the developmental period of adolescence increases the susceptibility to many
neuropsychiatric diseases in adulthood, including alcohol drinking and anxiety-like behaviors. Social isolation is
a particularly profound stressor with increasing human relevance, especially during the COVID-19 pandemic,
when millions of adolescents have faced prolonged periods with limited and intermittent social interactions with
peers. The endocannabinoid system (ECs) is critically involved in brain development and modulates synaptic
transmission processes, including those in the central nucleus of the amygdala (CeA), a hub of stress and anxiety
processing. A growing body of evidence indicates that adolescent social isolation stress and alcohol drinking
hijacks the developing brain by disrupting the ECs and resulting in long-lasting synaptic neuroadaptations that
predispose to alcohol use disorder (AUD), anxiety, aggressive behaviors, and social interaction deficits. Unlike
adult alcohol exposure, the synaptic and behavioral effects of adolescent binge drinking often do not recover
following periods of abstinence, suggesting that experiencing social isolation and alcohol drinking during
adolescence has the potential to permanently disrupt the brain’s developmental trajectory. Here, I will utilize a
modified model of intermittent social isolation stress to examine 1) the effect of intermittent social isolation on
alcohol intake and preference during adolescence (PND28-56) in male and female Wistar rats and 2) identify
the individual and synergistic consequences of adolescent social isolation and alcohol drinking on the EC-
mediated mechanisms contributing to the anxiety-like behaviors and social interactions long-term effects.
Additionally, I will assess the ECs neuroadaptations in the CeA and validate ECs as a potential drug target (AIM
1/K99). My hypothesis is that adolescent isolation stress and alcohol drinking induce lasting alterations on
GABAergic and glutamatergic signaling in the CeA via maladaptive functions (downregulation) of the ECs (AIM
2/K99-R00). Finally, given that previous work as well as my preliminary data suggest that manipulating the ECs
reduces alcohol drinking and anxiety-like behaviors, I will assess whether increasing endocannabinoids’ tone
(i.e., 2-AG) during the abstinence period post-adolescence, by blocking ECs enzymatic degradation, is
efficacious in reducing the anxious phenotype and in preventing drinking relapse in adulthood (AIM 3/R00). The
K99 portion of this proposal involves extensive training using molecular and electrophysiological approaches to
probe the functional protective role of the ECs system against later escalations in alcohol drinking and anxiety-
like behaviors. Collectively, these experiments will provide critical insights into the impact of adolescent isolation
stress and alcohol drinking on the resulting behavior and synaptic transmission in both sexes and will validate
the ECs as druggable target for AUD and comorbid behaviors. The technical and conceptual training I will receive
during this award will equip me with the multidisciplinary approach needed to continue this research line
independently.

Public health relevance
PROJECT NARRATIVE Adolescent social isolation stress coupled with alcohol drinking is a major public health problem that has been exacerbated by the current COVID-19 pandemic and can lead to lasting disruptions of brain functions. The proposed longitudinal experiments will characterize the synergistic and individual consequences of social isolation stress and alcohol exposure across the lifespan. By elucidating the endocannabinoid-related mechanisms underlying the long-term impact of social isolation stress and alcohol on adolescent and adult brain, these studies will also identify and validate potential therapeutic targets and drug candidates that can reverse and/or prevent stress and alcohol’s developmental effects on synaptic functions and behavior.